A Team-Based and Technology Driven Adherence Intervention to Improve Chronic Disease Outcomes

Project Summary
More than 50% of adults treated for diabetes, hypertension, or lipid disorders have suboptimal medication
adherence, a prominent barrier to continued improvement in chronic disease care in the United States. Primary
care providers (PCPs) often fail to identify medication nonadherence and/or have insufficient time and training
to address underlying reasons for it. In this project, we propose a patient-centered and technology-driven
strategy to identify patients with adherence issues and apply a team approach to help them achieve evidence-
based personalized goals for glucose, blood pressure, or lipids. This intervention extends the use of a widely
available clinical decision support (CDS) infrastructure to support a model of care that, for the first time outside
of a fully integrated care environment, will integrate retail pharmacists within the primary care team. The
intervention relies on a continuous health informatics loop to do the following: (a) identify high-risk patients
with adherence problems at the point of care by expanding the capability of an electronic medical record
(EMR)-linked CDS to capture pharmacy claims data and measure adherence; (b) establish and maintain an
auto-populating up-to-date registry of patients identified for proactive pharmacist outreach at retail pharmacy
locations; (c) implement a pharmacist outreach strategy based on an information-motivation-behavioral
framework recommended by the World Health Organization with demonstrated ability to influence adherence
across a variety of clinical applications; and (d) coordinate care and adherence information by incorporating
pharmacist assessment and action plans into CDS at subsequent office encounters. The intervention was
conceptualized and designed with extensive input from PCPs and in collaboration with pharmacy leaders to
ensure efficient integration with existing clinic staff and workflows. We will test the effectiveness of this
intervention using a cluster randomized controlled trial in 20 primary care clinics with approximately 50,000
adults with suboptimally controlled diabetes, hypertension, or lipid disorders. We will evaluate intervention
impact on objective measures of adherence (proportion of days covered) and changes in hypertension control,
glycemic control, and statin use. We will assess health care costs and long-term cost-effectiveness using
microsimulation modeling, and in secondary analysis, assess intervention impact on primary nonadherence,
10-year cardiovascular risk, the care experience from the provider, patient, and key stakeholder perspectives,
and on patient-reported medication adherence measures. This project builds upon previous National Institutes
of Health funded research conducted by our team and (a) extends the capabilities of EMRs already used in the
care of tens of millions of Americans, (b) electronically integrates pharmacists within the primary care team, (c)
has the potential to significantly improve chronic disease care and translate massive investments in health
information systems into tangible health benefits for large numbers of patients.

Public health relevance
Project Narrative Poor adherence to medications for chronic diseases is common, but providers often fail to identify patients with adherence issues and/or lack adequate time to address them. New strategies are needed to provide nonadherent patients the support they need to make fully informed choices about their medications and understand the impact of adherence on clinical outcomes. In this project, we implement and evaluate a team- based, informatics-driven intervention that integrates primary care clinical decision support with active outreach from pharmacists. The intervention will proactively (1) identify and address nonadherence for adults with chronic diseases; (2) improve management of previously uncontrolled blood pressure, blood sugar, and lipid disorders; (3) increase patient involvement in medication decision making; and (4) develop informatics systems that integrate retail pharmacists within the primary care team.